Spirochete Neutrophil Interactions Initiate Vascular Inflammation Promoting Aortic Endothelial Dysfunction

Project Summary/Abstract
Periodontitis is a chronic inflammatory condition affecting about 47% of the population in the United States, and
is a potential risk factor for systemic co-morbidities as individuals with poor oral hygiene are 30% more likely to
develop adverse cardiovascular events. Periodontitis is characterized by a dysbiotic subgingival microbial
community, with a high abundance of spirochetes, including Treponema denticola, together with local gingival
inflammation allowing for transmigration of bacterial products and inflammatory mediators to the circulation.
Inflammation-driven endothelial cell dysfunction leading to vascular permeability is a critical factor in initial
cardiovascular disease (CVD) pathogenesis. Emerging evidence has implicated neutrophil infiltration in the early
stages of endothelial cell dysfunction and progression of CVD. T. denticola has been detected in human
atheromas, along with active propagation to the aortic tissue with neutrophil-rich immune cell recruitment in
murine models of oral T. denticola infection. T. denticola and T. denticola-produced outer-membrane vesicles
(OMVs) dysregulate neutrophil function along with promoting distinct neutrophil cytokine profiles characterized
by the secretion of the understudied IL-6 family cytokine, Oncostatin M (OSM). OSM is elevated locally in the
periodontal pocket and systemically during periodontitis. Furthermore, OSM has also been implicated in
cardiovascular pathologies and may support endothelial changes in atheroprone environments. Effective cellular
junctions and functional signaling are required to maintain vascular endothelial integrity and disruption of these
molecular complexes together with cellular activation are early hallmarks of endothelial dysfunction leading to
atheroma development. A gap in knowledge remains in the mechanistic understanding of how neutrophil
cytokine signaling and spirochete interactions orchestrate initial endothelial changes to promote vascular
pathology. The overall objective of this project is to characterize oral bacteria and inflammatory cytokine
signaling processes which promote aortic endothelial cell dysfunction. It is hypothesized that T. denticola-
mediated interactions and neutrophil-derived OSM signaling support endothelial junctional integrity and
inflammatory signaling pathways to promote a pro-atheroma vascular environment. Two aims will be pursued to
test this hypothesis: 1) identify molecular mechanisms of endothelial dysfunction during exogenous OSM priming
and 2) investigate the molecular regulation of endothelium activation by T. denticola exposure. To achieve these
aims, a variety of methods will be used; including immunological assays, dynamic in vitro models, microscopy,
flow cytometry, animal models, and microbiological techniques. Completion of this project will provide valuable
insight into the interactions of spirochetes, inflammatory cytokine signaling, and neutrophils to promote
endothelial cell dysfunction. The mentoring and proposed training plan will be performed within a multidisciplinary
research environment at the University at Buffalo, which will provide the trainee with both the scientific and
professional development skills necessary to transition to the next stage of a successful research career.

Public health relevance
Project Narrative Periodontitis is a prevalent chronic oral inflammatory condition with a known bi-directional association with co- morbidities including cardiovascular diseases. Treponema denticola is an understudied bacteria prevalent in the periodontal dysbiotic subgingival plaque as well as being associated with atherosclerotic lesions and vascular inflammation in human cardiovascular diseases. A better understanding of how this organism, its associated virulence factors and unique pro-inflammatory cytokine signatures initiate endothelial dysfunction will aid in development of more effective strategies to maintain both oral and overall systemic health.